Scalable Computational Methods for Genealogical Inference: from species level to single cells

PROJECT SUMMARY
Massive amounts of genomic data are currently being generated, providing unprecedented opportunities for
biomedical researchers to characterize various biological components and processes. In order to utilize these
data to make new biological discoveries and improve human health, accurate models and scalable computational
tools need to be developed to facilitate analysis and interpretation. The central objective of this project is to
address this challenge by developing more realistic probabilistic models, scalable algorithms, and user-friendly
software tools to enable the biomedical research community to better harness large genomic data. Many prob-
lems in genomics rely on computational methods for inferring genealogical information from large sequence data
and interpreting the reconstructed trees. In this application, we propose to make significant strides towards im-
proving this line of research by developing a suite of robust and scalable algorithms for probabilistic models of
molecular evolution and genealogical inference across multiple timescales. We will achieve our goal by carrying
out the following specific aims: 1) A fundamental problem in statistical analysis of molecular evolution is estimat-
ing model parameters, for which maximum likelihood estimation (MLE) is typically employed. Unfortunately, MLE
is a computationally expensive task, in some cases prohibitively so. In Aim 1, we will tackle this problem by
combining a novel MLE framework and modern optimization techniques to develop a broadly applicable
computational method that achieves several orders of magnitude speedup in MLE for general models of
molecular evolution. The ability to estimate model parameters at unprecedented speed will transform the way
that phylogenetic analysis is performed and enable the community to consider more complex, realistic models
than previously possible. We will apply our tools to improve phylogenetic inference for two clinically important
superfamilies of membrane proteins in humans, namely G protein-coupled receptors and Solute carrier trans-
porters. 2) Because of meiotic recombination, the genetic variability within humans cannot be represented by a
single tree. Instead, there are millions of different trees across the genome, where each position in the genome
will tend to have its own tree that differs only minimally from the trees in nearby sites. The collection of all these
trees, and the set of recombination points creating new trees, is represented by the Ancestral Recombination
Graph (ARG), which has a number of applications in human genetics. Despite substantial recent progress on
reconstructing ARGs, however, current methods are either too slow to scale up to large data sets, or they do not
sample ARGs accurately from the correct posterior distribution. In Aim 2, we will develop a new computational
method to improve ARG sampling. We will test the method extensively on simulated data, develop a number of
applications, and generate genome-wide ARGs for several human data sets to facilitate biological discoveries. 3)
Applications of genealogical inference methods have been rapidly growing in single-cell genomics. In particular,
advances in CRISPR/Cas9 genome editing technologies have enabled lineage tracing for thousands of cells in
vivo, and the problem of reconstructing trees from such data has received considerable attention recently. In
Aim 3, we will develop scalable algorithms to reconstruct time-resolved single-cell trees for thousands of
cells sampled at multiple time points. We will also develop a novel statistical method grounded in rigorous the-
ory to improve tree-based fitness inference. We will apply the methods developed here to study cancer evolution
as well as B cell affinity maturation in germinal centers.

Public health relevance
PROJECT NARRATIVE This project will develop scalable computational methods for estimating probabilistic model parameters and in- ferring genealogical information across different timescales, which will significantly facilitate the analysis and interpretation of human genome variation as well as single-cell genomics data. The user-friendly software tools stemming from this research will be broadly applicable to scale up inference under many settings, thereby en- abling the biomedical research community to better harness massive genomic data to improve human health. In particular, the methods developed in this project will be applied to study the biology of metastasis in cancer and antibody maturation in the immune system.